ShapeWorksStudio: An Integrative, User-Friendly, and Scalable Suite for Shape Representation and Analysis

Project Summary
The morphology (or shape) of anatomical structures forms the common language among clinicians, where ab-
normalities in anatomical shapes are often tied to deleterious function. While these observations are often quali-
tative, ﬁnding subtle, quantitative shape effects requires the application of mathematics, statistics, and computing
to parse the anatomy into a numerical representation that will facilitate testing of biologically relevant hypotheses.
Particle-based shape modeling (PSM) and its associated suite of software tools, ShapeWorks, enable learning
population-level shape representation via automatic dense placement of homologous landmarks on image seg-
mentations of general anatomy with arbitrary topology. The utility of ShapeWorks has been demonstrated in a
range of biomedical applications. Despite its obvious utility for the research enterprise and highly permissive
open-source license, ShapeWorks does not have a viable commercialization path due to the inherent trade-off
between development and maintenance costs, and a specialized scientiﬁc and clinical market. ShapeWorks has
the potential to transform the way researchers approach studies of anatomical forms, but its widespread ap-
plicability to medicine and biology is hindered by several barriers that most existing shape modeling packages
face. The most important roadblocks are (1) the complexity and steep learning curve of existing shape modeling
pipelines and their increased computational and computer memory requirements; (2) the considerable expertise,
time, and effort required to segment anatomies of interest for statistical analyses; and (3) the lack of interoperable
implementations that can be readily incorporated into biomedical research laboratories. In this project, we pro-
pose ShapeWorksStudio, a software suite that leverages ShapeWorks for the automated population-/patient-level
modeling of anatomical shapes, and Seg3D – a widely used open-source tool to visualize and process volumet-
ric images – for ﬂexible manual/semiautomatic segmentation and interactive manual correction of segmented
anatomy. In Aim 1, we will integrate ShapeWorks and Seg3D in a framework that supports big data cohorts to
enable users to transparently proceed from image data to shape models in a straightforward manner. In Aim 2,
we will endow Seg3D with a machine learning approach that provides automated segmentations within a statisti-
cal framework that combines image data with population-speciﬁc shape priors provided by ShapeWorks. In Aim
3, we will support interoperability with existing open-source software packages and toolkits, and provide bindings
to commonly used programming languages in the biomedical research community. To promote reproducibility,
we will develop and disseminate standard workﬂows and domain-speciﬁc test cases. This project combines an
interdisciplinary research and development team with decades of experience in statistical analysis and image
understanding, and application scientists to conﬁrm that the proposed developments have a real impact on the
biomedical and clinical research communities. Our long-term goal is to make ShapeWorks a standard tool for
shape analyses in medicine, and the work proposed herein will establish the groundwork for achieving this goal.

Public health relevance
Project Narrative ShapeWorks is a free, open-source software tool that uses a ﬂexible method for automated construction of sta- tistical landmark-based shape models of ensembles of anatomical shapes. ShapeWorks has been effective in a range of applications, including psychology, biological phenotyping, cardiology, and orthopedics. If funded, this application will ensure the viability of ShapeWorks in the face of the ever-increasing complexity of shape datasets and support its availability to biomedical researchers in the future, as well as provide opportunities for use in a wide spectrum of new biological and clinical applications, including anatomy reconstruction from sparse/low- dimensional imaging data, large-scale clinical trials, surgical planning, optimal designs of medical implants, and reconstructive surgery.